BONE MARROW BIOPSY IN HIV POSITIVE INDIVIDUALS

The study is aimed at understanding the effects of HIV-1 on bone marrow structure and function, particularly on blood formation. Patients in varying stages of HIV disease, including asymptomatic and symptomatic seropositive patients, will be followed prospectively over a period of 4 years with bone marrow aspirates and biopsies.